Administration and Imaging

This grant will be under the administrative cognizance of the Department of Radiology within the School of Medicine. The department is professionally supported by the School of Medicine staff and the central university Office of Sponsored Programs. The co-PIs of the POI, KA Krohn and JF Eary, meet weekly with the project and core directors to review the progress of the research and to insure effective use of core resources by scheduling imaging studies. In addition, the administrative core will include support for patient imaging and regulatory compliance as well as data sharing via caBIG and archiving images with NCI.

Public health relevance
This core provides important organization to a program that is spread over several departments and two campuses. The imaging instrumentation at UWMC and SCCA is essential for each of our projects and a coordinated effort for data sharing will help integrate this program with our Comprehensive Cancer Center and with the NCI Cancer Imaging Program.